Sickle Cell Scholar Component

The Sickle Cell Scholar training program is an integral part of the education component of the Comprehensive Sickle Cell Center grant. The Sickle Cell Scholar will be chosen according to the guidelines in the RFA. Under the auspices of the Los Angeles Sickle Cell Center, the scholar will have the opportunity to do clinical and translational research related to the efficacy of L-glutamine in ameliorating the symptoms of sickle cell disease, the genesis of cardiac dysfunction in transfused sickle cell patients, the health services research related to provision of adult care, or translational research related to the role of viscosity in alteration of blood flow and oxygen delivery in humans and the use of engineering techniques to detect evidence of sickling. Unique to this program, the scholar will be supervised by the Center education director who is a cell biologist and doctoral level educator. This individual will be responsible for setting educational milestones and systematically monitoring the progress of the scholar to the training program. Also described here is a plan for the management of the summer high school student program that will also be run by the Center education director.